A novel monobody-drug conjugate to treat mutant KRas pancreatic cancer.

Project Summary
Tezcat Biosciences is developing novel receptor-independent intracellular drug delivery
technology with a unique mechanism of action to treat the most recalcitrant cancers, such as
mutant RAS pancreatic cancer. Pancreatic ductal adenocarcinoma cancer (PDAC) is associated
with a dismal 5-year survival rate and pancreatic cancer patients today have virtually the same
therapeutic options available to patients decades ago. This dearth of effective treatments is due
in part to the notorious difficulty in targeting the genetic driver of PDAC, oncogenic RAS, as well
as features of the PDAC tumor microenvironment itself which obstruct drug delivery. We have
observed that mutant RAS PDAC cells display high levels of macropinocytosis, a nutrient
scavenging process that facilitates the bulk engulfment of extracellular fluid and its solutes. Our
drug candidate, TZT-102, utilizes our proprietary macropinocytosis-selective monobody that
carries an FDA-approved cytotoxic payload (MMAE). Results from our Phase I STTR project
demonstrate that TZT-102 has robust anti-tumor activity in mutant RAS PDAC xenograft and
orthotopic models without displaying systemic toxicity. Based on the success of our Phase I aims,
we propose a Phase II SBIR program for investigators at Tezcat to advance TZT-102 through
Specific Aims that will execute on bioanalytical assay validation (Aim 1) and further in vivo survival
studies utilizing patient-derived xenografts, including those that are resistant to KRASG12D
inhibitors (Aims 2 & 3). Tezcat has entered into a license agreement with NYU Langone Health
for exclusive, worldwide rights to the technology being developed. The commercialization strategy
will be based on further development through Phase II SBIR studies and towards IND status and
first-in-human clinical trials through a strategic partnership. Thus, we expect this Phase II SBIR
to provide additional support for pursuit of GMP protocols and IND-enabling studies to support
IND submission with the FDA.

Public health relevance
Project Narrative: Tezcat Biosciences is an early-stage biotechnology company focused on developing innovative therapeutics to treat mutant RAS cancers. In this Phase II SBIR, Tezcat is continuing development of their protein-drug conjugate, TZT-102, for the treatment of mutant RAS pancreatic cancer.